Causal Gene Prioritization in Systemic Sclerosis: Multi-Omics Analyses from Population Genetics to Single Cell Biology

Project Summary/Abstract
This proposal outlines a five-year research career development program aimed at prioritizing
genes that are potentially causal to the development of systemic sclerosis (SSc) using multi-
omics analyses. The candidate is currently an Instructor in Medicine at the Columbia University
Irving Medical Center and a rheumatologist at the New York-Presbyterian Hospital. The
proposal leverages the candidate's established research background in genetic epidemiology
and computational biology and broadens his expertise to encompass multi-omics analysis
across the realms of both population genetics and single-cell sequencing. The proposed
research and training will equip the candidate with a distinctive set of cross-disciplinary skills,
fostering his transition to an independent physician-scientist in -omics science and precision
medicine in SSc.
SSc is a systemic autoimmune rheumatic disease with a 10-year survival rate of 71.7%, a
statistic that has unfortunately remained stagnant over the past two decades. There is an unmet
need to understand the causal biological signals that drive organ-specific disease activity. With
the advent of multiple population quantitative trait loci (QTL) datasets, which concurrently
measure genomic variation and other -omics data, innovative methodologies have been
developed to predict the causal genes which mediate the genomic loci discovered in the
genome-wide association studies (GWAS). The understanding derived from population-level
post-GWAS analyses can generate pivotal hypotheses that guide the analyses of single-cell
sequencing data. The specific aims of this proposal are: 1. Prioritize putative causal genes
associated with SSc using population-level post-GWAS analyses, including the transcriptome-
wide association study (TWAS), proteome-wide association study (PWAS), and multi-omics
Mendelian randomization. 2. Discover key pathological B cell states using simultaneous scRNA-
seq with scCITE-seq and scBCR-seq, with data-driven and hypothesis-driven analyses. The
proposed research could enhance our understanding of SSc mechanisms and generate
hypotheses for the discovery of novel therapeutic targets and biomarkers.

Public health relevance
Project Narrative Systemic sclerosis is a rare, yet serious disease characterized by the hardening and scarring of the skin and internal organs. Due to a limited understanding of the disease, effective treatments are scarce. The proposed research aims to investigate the genes that potentially drive disease development by analyzing genetic data from large population studies, and subsequently conducting experiments on specific immune cells.